Enhance Cancer Therapeutics with 3-in-1 CAR T Cells

PROJECT SUMMARY
Recent evidence highlights the significant role of tumor-associated myeloid cells (TAMCs), including tumor-
associated macrophages (TAMs) and myeloid-derived suppressor cells (MDSCs), in promoting cancer
immunosuppression and progression. In glioblastoma (GBM) and certain other cancers, TAMCs can constitute
up to 50% of the tumor's mass, playing pivotal roles in dampening the immune response and adversely affecting
patient survival. Thus, targeting TAMCs presents a promising strategy to overcome the limitations of current
cancer treatments. However, drug development in this area remains underexplored. Our research focuses on the
leukocyte-associated immunoglobulin-like receptor 1 (LAIR1), which is prominently expressed on TAMs and is
crucial in mediating their immunosuppressive function. We have identified a previously unrecognized
immunosuppressive circuit involving LAIR1, Factor XIII A (FXIII-A), and Collagen IV across various cancer
types. LAIR1 activation prompts TAMs to release FXIII-A around tumor cells, leading to increased deposition
and structural organization of Collagen IV, shielding tumors from immune attacks. Inhibiting LAIR1, either
through genetic knockout (LAIR1-/-) or antibody blockade (aLAIR1), disrupts this immunosuppressive pathway,
resulting in enhanced populations of peripheral and tumor-infiltrating memory CD8 T cells, a phenotypic shift
of TAMs toward an M1 profile, and reduced tumor-collagen deposition. These collective effects contribute to
normalizing the TME and promote more effective interactions between T cells and tumor cells, leading to a
robust antitumor response. Notably, aLAIR1 demonstrates enhanced antitumor efficacy as a standalone
treatment or combined with Chimeric Antigen Receptor (CAR) T cell therapy in preclinical models resistant to
chemo/radiation/anti-PD-1 treatment. These findings position aLAIR1 as a promising strategy for cancer
immunotherapy. However, the blood-brain barrier (BBB) and tumor physical barrier (TPB) pose a significant
challenge for developing effective antibody therapies for brain tumors and other cancers.
This study aims to overcome these barriers by evaluating the antitumor efficacy and toxicity of our 3-in-1 triple-
functional CAR platform, which combines 3 critical functions: precise tumor targeting, enhanced CAR T-cell
tumor trafficking/penetrating, and inhibition of TAMCs through LAIR1 signaling blockade. These functions aim
to reshape the TME and enhance antitumor response. Two aims are proposed: Aim 1: Testing antitumor efficacy
of the CAR T cells in a clinically relevant GBM model. Aim 2: Conducting a pilot toxicology study of the 3-in-1
CAR T cells. Successful completion of this study will validate the capability of the 3-in-1 CAR T cells to overcome
the BBB and TPB. Moreover, it will lay the groundwork for phase II, an IND-enabled study aimed at clinical
translation and technology commercialization.

Public health relevance
RESEARCH NARRATIVE This study provides vital information on a novel immune checkpoint, the LAIR1 signaling network in cancer, and determines how its blocking strategy using the CAR T cell-delivering system (3-in-1) affects the efficacy of cancer immunotherapy in GBM and other hard-to-treat cancers, ultimately leading to improved cancer treatment outcomes in clinical settings.